Home-based plasma self-collection device for remote diagnosis and monitoring of AD-associated biomarkers

Project Summary/Abstract
Lo Bio has developed the P1™, a microtube that collects whole blood and separates it into lab quality
cell-depleted liquid plasma at the point-of-draw. Our innovation uses proprietary magnetic beads designed
to capture and separate blood cells from plasma in 1 min with over 99.9% efficiency. The P1 will enable the
collection of laboratory-quality, high-yield, and stable plasma in essentially any remote environment and at a low
cost. While the P1 can improve access to diagnostics broadly, industry experts suggest to us that helping to
diagnose and monitor participants of clinical studies for Alzheimer’s Disease (AD) is one of the most important
applications today. In particular, demonstrating its compatibility with the p-Tau 217 biomarker is highly important
given that it is one of the most studied biomarkers and is recognized by the scientific and clinical communities
as one of the most promising biomarkers for AD diagnosis and monitoring.
In this application we propose to advance key elements of the P1 technology, including optimize antibody binding
efficiency, demonstrate sample biocompatibility with p-Tau 217 analysis, and conduct pre-clinical validation
comparing P1-separated plasma against centrifuged plasma for plasma quality.
Aim #1. Develop Custom aRBC Monoclonal Antibody. We will work with Lampire Biologicals to
develop a custom mouse monoclonal antibody and demonstrate comparable plasma quality to
centrifugation.
Aim #2: Conduct equivalence and sample stability study. To validate use for AD clinical trials, we will
demonstrate strong correlation (R>0.9) between P1 and centrifuged plasma for p-tau 217 quantitation.
We will also conduct a 3-day stability study to demonstrate that ptau217 is stable in P1 plasma for at
least 24 hours of simulated shipping (<15% bias).
Aim #3: Complete implementation study. We will conduct a 15-person usability and analytical study
to validate that self-collected plasma produced by the P1 is suitable for use in decentralized settings.
Success is defined as having >90% successful use of P1 by lay-users and >95% equivalency between
P1 and centrifuged plasma.

Public health relevance
Project Narrative: The proposed work is relevant to public health as the ultimate goal is to develop an at-home plasma collection device to enable the more equitable decentralized clinical trials, specifically for Alzheimer’s related diseases. This technology will directly contribute towards the development of more responsibly tested medical devices and therapeutics.